INHALED HUMAN INSULIN VS USUAL SUBCUTANEOUS HUMAN INSULIN THERAPY IN NIDDM

The purpose of this pilot study is to collect data to determine whether glycemic control can be achieved at least as effectively with an insulin regimen involving pre-meal inhaled insulin plus a single bedtime Ultralente injection as with a conventional subcutaneous insulin regimen involving 2-3 injections per day.